UT Summer Undergraduate Research Experiences in the Environmental Health Sciences

UT Summer Undergraduate Research Experiences in the Environmental Health Sciences
Project Summary
This research and educational intervention effort proposes to recruit ten talented and diverse underrepresented
undergraduate students from across the U.S. to the University of Tennessee (UT) campus for immersive ten-
week summer research experiences in the biomedical sciences. In a unique partnership between the Center for
Environmental Biotechnology, the Department of Mechanical, Aerospace, and Biomedical Engineering, and the
Office of Undergraduate Research, we are proposing to implement research challenges for underrepresented
undergraduate students under the general theme of ‘health, science, and the environment’. For this effort, we
have enlisted an academically (MD, Ph.D., and/or DVM credentials across 11 departmental affiliations) and
culturally (African-American, Hispanic and Latino, rural Appalachian, female, first-generation) diverse group of
20 faculty role models, 60% with a lineage of NIH funding, to provide mentorship and rigorous hands-on research
training to our students with a focused goal of building self-efficacy and strengthening persistence toward their
pursuit of an advanced degree in the biomedical sciences. Complementary to their research responsibilities,
students will also engage in workshops and classroom instruction on experimental design, ethics, statistical
analysis, laboratory management, entrepreneurship, and science communication to ensure strong scholarship
and career development metrics are upheld across the science, technology, engineering, mathematical, and
medical science (STEMM) disciplines. Student research will culminate in a campus-wide and publicly open
poster session that will be jointly held among all of UT’s various internal and external summer undergraduate
research programs. A robust recruitment plan has been developed to capture our desired student clientele from
historically black, Hispanic-serving, and other smaller non-research intensive liberal arts colleges that provide
excellent instruction but little in the way of independent laboratory inquiry. As well, an evaluation plan is in place
for surveying immediate and long-term goal attainments, an Advisory Committee has been convened for
independent project oversight and counsel, and a dissemination plan will be implemented to promote local and
national distribution of our findings through research scholarship by our undergraduate participants and their
faculty mentors and use of our undergraduates as science spokespersons within our summer K-12 outreach
activities. Collectively, this outreach and intervention mission will enhance the retention of underrepresented
minorities in the STEMM disciplines and serve to bridge the racial, ethnic, and gender disparity gaps inherent to
the U.S. biomedical higher education and workforce fields.

Public health relevance
Project Narrative College students from underrepresented minority backgrounds pursuing degrees in the science disciplines experience unique educational and cultural barriers that contribute to a loss in motivation to persist in their chosen degree paths, the consequences of which have resulted in a workforce that traditionally experiences significant disparities in its engagement of minority scientists. To address these inequalities, the University of Tennessee’s Center for Environmental Biotechnology, Department of Mechanical, Aerospace, and Biomedical Engineering, and Office of Undergraduate Research have partnered to provide an immersive summer research program that specifically targets underrepresented undergraduate students from across the U.S. in challenging hands-on independent research designed to enrich self-efficacy and heighten persistence toward the pursuit of advanced degrees in the biomedical sciences.